GENERIC AND BRAND-NAME VERAPAMIL AND ITS METABOLITES IN ELDERLY AND YOUNG

To test the hypothesis that there will be greater differences in the bioavailability and pharmacokinetics of various verapamil formulations in the elderly than in young subjects.